Data Mining and Machine Learning Guided QM/MM and QM-Cluster Modeling of Enzymatic Reactions

Project Summary/Abstract
Computational modeling methods have been widely applied in protein structure prediction, drug
discovery and enzyme bioengineering to provide atomic-level insight into enzymatic reactions and
functions. Accuracy and efficiency are the two goals that motivate the development of new
methods in this field. However, the methodological best practices are still lacking in achieving high
throughput and accuracy. In quantum mechanics/molecular mechanics (QM/MM) and QM-cluster
enzyme modeling, series of decisions such as molecule partitioning into QM and MM regions,
protonation states of residues, and computational setting rely on good understanding of the
problem and knowledge of the enzyme as well as available computational methods. In this
proposed project, machine learning methods will be applied in computational enzyme modeling
for a better and more systematic solution. The proposed project is innovative as it combines a)
data mining and machine learning on published experimental and computational works which will
efficiently and systematically collect knowledge for research; b) machine learning methods can
weigh different components of computational modeling and make optimal decisions automatically;
c) the results of this work will provide a rational strategy for accurate and efficient QM/MM and
QM-cluster simulations in future studies of different protein systems, drug design and even other
scientific research domains. The proposed project will focus on two enzyme systems that will
serve as case studies: a) Chorismate Mutase which is a potential target for designing antibiotics
and b) the Cytochrome P450 superfamily of metalloenzymes which are largely involved in drug
metabolism via various reaction mechanisms.

Public health relevance
Project Narrative The computational enzyme modeling community is continuously seeking resources for a better understanding of enzyme structure, function and enzymatic reaction pathways, which will greatly advance drug design and enzyme bioengineering. Artificial Intelligence will be employed to facilitate computational modeling of two enzyme systems: 1) Chorismate mutase enzymes, which catalyze pericyclic rearrangement reactions to produce aromatic amino acids in bacteria, are a potential target for designing antibiotics; and 2) Cytochrome P450 which is a superfamily of enzymes that play key roles in the metabolism of drugs and other xenobiotics. Rigorous and automated quantum mechanics and molecular mechanics (QM/MM) and QM-clustering modeling design will be generated by data mining and machine learning techniques from existing and appreciative knowledge; and the output of this project will be systematic and well-formatted data as well as data mining and machine learning models which can generate computational protocol of these two enzymes, which potentially can be transferred to the study of other enzyme systems.